The Proactive Screening and diagnosis of mild cognitive impairment and depression in patients aged 65 and over: An Implementation Study

Project Summary
The proposed program aims to complete the work needed for Miro Health to finalize FDA
approval for the automated diagnosis of amnestic MCI (aMCI) which often leads to Alzheimer’s
and related dementias (ADRD), non-amnestic MCI (naMCI), and late life depression (LLD). The
work involves the optimization of our data processing pipeline and digital signal processing
methods and the refinement of our machine learning algorithms based on data types collected
via real-world settings rather than through clinical research environments. Our objective is to
improve patient outcomes and reduce healthcare costs by providing a universally available, self-
administered mobile brain assessment and diagnostic platform.
Prospective study participants will be recruited from clinics and the community. Participants will
participate in novel mobile assessments and traditional cognitive and psychiatric assessments.
The resulting data will be used to: (1) Assess usability of Miro for remote assessment; (2)
Improve quantification of functional abilities and add RDoC metadata labels to Platform; (3)
Refine A.I. models for the diagnosis of aMCI, naMCI, LLD, and comorbid MCI+LLD.
Because late-life depression often mimics MCI and co-occurring depression may hasten the
progression of MCI toward dementia, the identification and proper treatment of depression may
resolve some apparent cases of MCI and slow the progression of others. Comorbid presentation
of brain disorders is common and the increased availability of tools that can accurately and
reliably identify complex comorbidities will improve care for our neediest patients.
The work involved in this program will enhance Miro Health’s Mobile Research Platform. The
introduction of RDoC metadata labels into our Mobile Research Platform’s metadata schema
will help standardize clinical research, dramatically reduce the number of staff needed per
study, and support massive scalability. Enhancing tools that yield precise, uniform data sets will
improve the power, interpretability, and generalizability of studies examining disease etiology,
genetic risk factors, and interventions.

Public health relevance
Project Narrative Mild cognitive impairment (MCI) leading to Alzheimer’s disease and related dementias (ADRD) represents a significant health and economic burden of the rapidly expanding 65+ population. The accurate detection and diagnosis of MCI and its common comorbidity, late-life depression (LLD), is essential for prolonging patient quality of life and developing advancements in research and treatment options. The purpose of the proposed program is to further develop and refine Miro Health’s A.I. to accurately detect and differentiate amnestic MCI (aMCI), non- amnestic MCI (naMCI), and LLD and to collect the sample sizes required for FDA approval of Miro Health’s automated aMCI, naMCI, and LLD diagnostic capabilities.